A Rapid Paper Strip Nucleic Acid Test for the Point of Care Detection of Zika virus

A Rapid Paper Strip Nucleic Acid Test for the Point of Care Detection of Zika virus CrossLife Technologies Inc. Project Summary/Abstract There are unmet needs for nucleic acids new diagnostics that can be applied at the point-of-care to detect Zika Virus (ZIKV) infections. A highly sensitive, simple paper strip molecular test that detects ZIKV at the point-of-care will be developed. The target sequences are amplified using the TARA (Template-Assisted Rapid Assay) technology which is composed of a template-dependent chemical transfer reaction with high turnover, gold nanoparticle-HRP and lateral flow readout. The test should be rapid (<30 minutes), and results in the appearance of colored bands that are detectable by eye.

Public health relevance
A Rapid Paper Strip Nucleic Acid Test for the Point of Care Detection of Zika virus CrossLife Technologies, Inc. RESEARCH & RELATED Other Project Information Narrative The rapid spread of Zika virus through the Americas, together with the connection of infection with microcephaly and Guillain-Barré syndrome, have driven this previously overlooked virus into the spotlight. The World Health Organization (WHO) predicts almost four million people could be infected with Zika virus in the Americas in the year 2016.